Core 08: Cyberinfrastructure Enhancement Core

The vision for the Cyberinfrastructure Enhancement (CE) Core is to strengthen the partner network, scale clinical accomplishments made in overcoming research related challenges during the previous cycle and create a sustainable growth model for clinical and translational infrastructure and workforce development in our state. To accomplish this vision, we will provide, update, and maintain “state of the art” computing and informatics resources; further developing the infrastructure to support the clinical and translational research projects of LA CaTS investigators with the goal of reducing Louisiana’s chronic disease burden. We will accomplish our goals by pursuing the following specific aims: Specific Aim 1. To facilitate clinical and translational research administration and data management using secure and proven cyberinfrastructure resources and tools, providing investigators a common ground through which to conduct research. We will accommodate hybrid working scenarios brought about by the pandemic, by adapting such a toolset to be as effective remotely, as it is from the researcher’s clinic or office. Specific Aim 2: Provide resilient video conferencing resources to support telehealth, educational, and community engagement efforts across the state to enhance communication to researchers and communities. CE will leverage the high-speed networks of Louisiana Optical Network Infrastructure (LONI) and a palette of proven technologies to support investigators and communities with poor access to information and care. Specific Aim 3: To leverage existing web-based tools for disseminating health-related research information and enhancing communication among all LA CaTS cores and stakeholders. CE will provide and support an advanced central coordination point for both internal and external communication that will serve as the primary repository of information about the LA CaTS Center for technical and lay audiences alike. The completion of these aims will significantly enhance and support investigators in their goal to address challenges in health care delivery and improve health outcomes in Louisiana by providing a wealth of computing resources that will greatly facilitate their research. Tighter collaboration with all cores will yield a more tailored approach highlighted by adoption, extension, and customization of available applications as well as the required infrastructure to provide scalable and reliable cyber solutions for all LA CaTS investigators.